FASEB SRC: The Post-transcriptional Control of Gene Expression Conference: Mechanisms of RNA Decay

PROJECT SUMMARY
The understanding that RNA degradation is critical for gene expression traces back to 1959 when Pardee, Jacob
and Monod demonstrated in a historical paper that there had to be an unstable intermediate directing protein
synthesis. More recently, the spectacular use of RNA interference to experimentally degrade specific mRNAs
has expanded the applications of understanding RNA decay mechanisms beyond any expectations. The clinical
applications in the post-transcriptional regulation/RNA field are only starting to be realized with the initial
development of Nusinersen/Spinraza® to successfully treat Spinal Muscular Atrophy and the more recent
description of Milasin® to treat a single patient through a personalized RNA therapy. Of course in late 2019 into
early 2020, RNA burst on to the global stage in a way we could not have predicted with the COVID-19 RNA virus
impacting life as we know it across the globe. Who would or could have guessed that RNA could also represent
a potential path back to a new normal via the rapid development and deployment of the first mRNA vaccines. All
of these examples highlight why The FASEB meeting on ‘Post-transcriptional Regulation of Gene Expression:
Mechanisms of RNA Decay’ is such a timely conference to support at this juncture. This meeting has developed
into a unique conference that brings together the leading experts in RNA decay in humans and other metazoan
animals, plants, fungi, viruses, and bacteria. This meeting is the 12th is a series of FASEB meetings on this topic
where there is a long tradition of sharing key discoveries, building collaborations, and contributing to career
development for junior scientists in the field. This meeting, which, after a two year delay due to the global
pandemic, will be held June 19-23, 2022 in Jupiter, Florida, is being co-organized by three leaders in the RNA
decay field, Dr. Anita H. Corbett from Emory, USA, Dr. Lori Passmore from the MRC in Cambridge UK, and Dr.
Cecilia Arraiano from the ITQB/Universidade NOVA de Lisboa, Portugal. Under this leadership, we propose
three specific aims: 1) Bring together the RNA degradation field and provide a forum for the presentation and
discussion of the latest advances; 2) Provide an inclusive environment for establishing collaborations between
researchers studying RNA degradation with different approaches and in different organisms; and 3) Encourage
productive interactions between a diverse group of both junior scientists and leaders in the RNA degradation
field. In keeping with a meeting goal and a common passion of the organizers, this meeting is organized with a
major commitment to inclusive excellence. Among the 35 invited speakers thus far, there are 18 women (51%)
and 17 men (49%). Each session is chaired by a co-chair team consisting of a senior scientist and a junior
scientist. Among the 18 co-chairs, 11 (61%) are women. We are excited to include five co-chairs who are from
groups traditionally underrepresented in STEM fields (28%). The long-term goal is to continue a successful
meeting series that addresses modern and timely topics in RNA decay and processing while building a diverse
and inclusive community of collaborative scientists and colleagues.

Public health relevance
PROJECT NARRATIVE During the recent COVID-19 pandemic, we have witnessed an increase in the importance of RNA in the lives of virtually everyone across the globe, from the COVID-19 RNA virus causing a scourge of illness, hospitalization and death, to the mRNA vaccines that offer a path back to something that will likely be a new normal. Beyond this example where RNA burst on to the world stage in a way we never could have predicted, many human genetic diseases are caused by defects in RNA processing and/or degradation pathways, including those diseases caused by mutations that inactivate an RNA decay enzyme or regulator and others where mutations change an RNA and thereby how fast the RNA is degraded. RNA decay is also a key regulator of both bacterial and viral pathogens, further illustrating key links between the RNA decay pathways that are the focus of this conference, and both human genetic and infectious diseases.